METHODOLOGY FOR DETERMINATION OF THE SERUM BACTERICIDAL TITER

It is sometimes clinically important to determine the extent to which a patient's antibiotic-containing serum can be diluted and still kill an infecting bacterium isolated from that patient. Such a determination provides a measure of the adequacy of antibiotic treatment. No satisfactory standardized technique has been established to determine such a serum bactericidal titer, and the reproducibility of the test has been poor. By careful attention to technique and an analysis of the component technical steps, progress toward a reproducible microdilution procedure has been made. Critical factors delineated thus far include the nature of the vessel in which the test is performed (irradiated plastic provides good results) and the need to introduce the inoculum for the test below the meniscus of antibiotic-containing serum and growth medium. Studies with several different antibiotic-organism combinations are in progress, and work is also under way to develop a "macro-tube" procedure.